Puberty-related development of fronto-amygdala circuitry in anxious youth: A multimodal neuroimaging study with ultra-high resolution MRI scanner (7T) - Supplement

Abstract
Pediatric anxiety disorders are an area of critical public health need. The past two decades have seen
substantial increases in both incidence and prevalence of anxiety psychopathology,1,2 trends which were
amplified by the COVID-19 epidemic and have recently been declared an emergency.3 Early adolescence and
the emergence of puberty is a pivotal moment wherein trajectories of anxiety symptoms begin to rise,
especially in girls.4,5 It is also a period of puberty-associated neuroplastic changes in brain networks associated
with emotion regulation and cognitive control.6,7
The parent R01 for this supplement investigates these puberty-related neurodevelopmental mechanisms
through the lens of an important brain circuit, vmPFC-amygdala connectivity, and its relationship to threat
reactivity, a known factor in anxiety disorders.8–10 This project proposes to extend the aims of the parent R01 to
another known factor, perseverative thought (PT), a transdiagnostic construct comprising negative, repetitive
thinking. PT in the form of worry and rumination has been associated with anxiety for decades.11 Although PT
can vary in different aspects, a hallmark of pathological PT is its uncontrollability.12–14 Thus, the ability to
disengage from PT is a potential factor of resilience. Recent years have seen interest in interventions targeting
PT, which enhance PT disengagement skills and appear effective against anxiety and depressive symptoms.15
However, the neural mechanisms of real-time disengagement from PT in adolescence remain unknown. The
study of neurodevelopmental mechanisms of PT disengagement therefore has substantial potential to improve
treatment efficacy and identify new neurobiologically-informed treatment targets.
The aim of the proposed project is to initiate a developmental study of PT disengagement by adapting a
paradigm previously published in adults16 for use in adolescents. Aim 1 proposes minor adaptations of the task
and behavioral pilot testing (N=30) to ensure understandability and tolerability in adolescents, then extending
to a neuroimaging context (N=30) to confirm its tolerability. Aim 2 proposes analyses of the pilot data and their
relationship to gender and symptomatology. The Candidate will expand her extant fMRI data analytic skills
through a training plan including formal didactics and supervision from the study PI.
This project will benefit from the parent PI’s extensive experience in neurodevelopment and
psychopathology and the wealth of mentorship and resources at the University of Pittsburgh. It will further the
Candidate’s goals of becoming an independent investigator by supporting research activities during the final
year of clinical fellowship and generating pilot data and testable hypotheses for a K23 award proposal.
Benchmarks for this award include presentations at scientific conferences and transition to a T32 postdoctoral
fellowship as the next steps towards a faculty position and independence as a physician-scientist.

Public health relevance
Project Narrative The past decade has seen a dramatic rise in incidence and prevalence of adolescent anxiety disorders, a trend magnified by the COVID-19 pandemic and recently declared a public health emergency by pediatric health organizations. Uncontrollable perseverative thought (PT) is a known contributing factor to development of anxiety disorders, but the mechanisms involved in the ability to disengage from PT have remained unclear, despite their importance in treatment of, and resilience against, anxiety and other forms of psychopathology. The proposed project will enable future study of PT disengagement in youth by adapting a PT disengagement paradigm previously used in adults to be age-appropriate for adolescents, and produce pilot data interrogating developmental neural mechanisms of PT disengagement in youth.